Functional And Multi-Omics Approaches To Elucidate The Regulation Of Proteasome Complex In Neurodegenerative Diseases

A hallmark feature of neurodegenerative diseases (NDs) is the accumulation and aggregation of disease-specific
proteins in distinct brain regions, leading to cellular dysfunction, loss of synaptic connections, and degeneration.
Often ignored nonetheless, a major component of all aggregates is ubiquitin, implicating that dysregulated
ubiquitin-proteasome mediated degradation is either a consequence of the disease pathogenesis or that
maladaptive proteasomal degradation is one of the common drivers of NDs.
In Alzheimer's disease (AD), neurofibliraly tangles (NFT) and neuritic plaques (NP) are decorated with ubiquitin,
and a wildly held belief but not rigorously tested is that tau aggregates impede proteolysis, causing a build-up of
ubiquitinated inclusion. Historically, this hypothesis has placed the proteasome-mediated proteolysis dysfunction
in AD distal to the disease pathogenesis. As a result, the field has shown little interest in the potential role of the
proteasome in determining the overall output of the ubiquitin-proteasome system (UPS) in Alzheimer’s and other
NDs. However, recent studies in the field recognize proteasome as a fundamental component of the regulation
of the UPS and protein homeostasis and that proteasome’s (dys)regulated levels and activity could predict the
outcome of protein build-up in AD and other NDs. While functional changes in the proteasome machinery may
constitute a common contributing factor to the pathogenesis of NDs, this co-occurring pathology across diseases,
in the past, has been studied in isolation from one another.
Using integrated multi-omics approaches combined with biochemical and functional approaches proposed in
Aim 1 and 2, this application will investigate how the UPS, specifically the proteasome complexes, are
affected in AD (in early and late stages), Progressive Supranuclear Palsy (PSP), Parkinson’s, and
Amyloid Lateral Sclerosis (ALS) and elucidate a possible shared mechanistic cascade of the failed protein
breakdown by the 26S proteasome across clinically diverse NDs.
Focusing primarily on AD pathogenesis as a representative disease, Aim 3 will interrogate the negative and
positive regulation of the NFE2L/Nrf1, a master transcript factor of the proteasome genes, to uncover the role of
Nrf1-mediated proteolysis in AD-afflicted brains, and propose a translational approach of proteasome-targeting
intervention that could overcome proteasome impairment and protein aggregation in AD.

Public health relevance
Functional changes in the ubiquitin-proteasome system (UPS) may constitute a contributing factor to the pathogenesis of neurodegenerative diseases (NDs). However, it is not known what cellular cascades are responsible for the impairment of protein degradation and the accumulation of toxic proteins across NDs. We propose to elucidate a possible shared mechanistic cascade of the failed protein breakdown by 26S proteasomes in clinically diverse diseases and propose a translational potential of proteasome-targeting interventions that could prevent or delay age-related diseases.